The Goizueta Alzheimer's Disease Research Center

SUMMARY/ABSTRACT: BIOMARKER CORE
SUMMARY/ABSTRACT: BIOMARKER CORE
The primary goals of the Biomarker Core are to support and enhance research activities both inside and
outside the Emory Goizueta Alzheimer’s Disease Research Center (GADRC) by 1) supporting standardized
biospecimen collection and preparation using best practices, 2) completing a set of standard analyses for
genetics and AD biomarker assays in CSF and plasma, and 3) measuring emerging plasma and CSF
biomarkers of disease. The standard genetics and biomarker assays will facilitate identification of at-risk
individuals and confirm AD-related pathology in symptomatic individuals. To facilitate research into the
complexity and heterogeneity of AD/ADRD, the Core will foster research to understand emerging biomarkers
and their performance in diverse populations. Longitudinal collection of common datasets, including clinical
information, CSF AD biomarkers, and genetic ancestry and polygenic risk scores, will provide foundations
upon which new and existing AD/ADRD biomarkers can be tested, evaluated, and confirmed. Exploratory
research in each of these areas should provide significant advances in CSF proteomic, plasma proteomic, and
genomic biomarkers. To accomplish these aims, the Core engages a group of talented investigators who will
bring their expertise to the GADRC and the larger research community. Each of these elements advance the
overall goals of the GADRC and will provide a wealth of data for new trainees.